Reducing Racial Disparities in SMM post COVID19: Assessing the integration of maternal safety bundles and community based doulas to improve outcomes for Black women

Abstract (Project Summary)
Black women experience stark disparities in pregnancy care, complications, and outcomes, compared to White
women. Recognizing, tracking and understanding patterns of severe maternal mortality (SMM) and associated
inequities by race/ethnicity, along with developing and carrying out interventions to improve the quality of
maternal care, are essential to reducing SMM and thereby maternal mortality. To date, there has been little
research specifically aimed at understanding whether the maternal health inequities as experienced by Black
women can be ameliorated through an integrated care model that includes engagement of mothers of color in
the planning and implementation of maternal safety bundles in addition to prenatal, birth and postpartum
support from community doulas. We intend to use the Health Impact Pyramid to develop, implement and
assess the effectiveness of such a system in reducing disparities in SMM and mortality. The data sources for
this study will include state-level and hospital-specific discharge data collected as part of the Alliance for
Innovation on Maternal Health (AIM) project; the Maternal Mortality Review Committee (MMRC); and the
Pregnancy to Early Life Longitudinal (PELL) data system, which focuses on population-level data needed to
examine health inequities among racial and ethnic minorities in Massachusetts. In addition to these existing
data sources, we intend to establish a data collection tool to assess doula services as well as analyze
qualitative data from interviews with black women, and focus groups with providers and doulas to explore the
effect of incorporating doula-provided services into prenatal, birth and postpartum care. This proposal has
three main study areas that will lead to a systematic understanding of ways to address and prevent SMM
among black women and thus, establish a foundation for the development, testing and scale-up of future
interventions to improve maternal health outcomes: 1) Use longitudinally linked hospital discharge data from
PELL (2008-2018) to characterize preconception, prenatal and postpartum hospital encounters among women
with SMM in order to identify key points where opportunities to intervene were missed. 2): Among hospitals
that serve black women, to assess the impact of implementing maternal safety bundles to ensure that black
women are receiving quality obstetric care 3): Examine how systems integrating community-based doula
support could decrease the inequities of SMM among black and white mothers. Our study will lead to a more
systematic understanding of pregnancy outcomes for Black women at highest risk of SMM, thus establishing a
foundation for development and testing of future interventions to improve maternal outcomes.

Public health relevance
Project Narrative (Public Health Significance) There is a paucity of research examining the intersection of race, ethnicity, maternal safety bundles, doulas, and maternal outcome in Black women at increased risk of severe maternal morbidity and mortality. The proposed mixed-methods study is the first systematic investigation of pregnancy complications and outcomes among Black women with whom maternal safety bundles including racial disparities, hemorrhage, and hypertension have been utilized and through the analysis of secondary state level data, this study will examine perinatal care, maternal outcomes, and healthcare utilization of Black women at increased risk of severe maternal morbidity and mortality compared with non-Latino white women. Additionally, through individual interviews with Black women and focus groups with obstetric health providers and doulas, the study will examine disparities and improve care by creating and disseminating a set of practice recommendations for maternity care for Black women at increased risk of morbidity and mortality.